Administrative Core

Dr Broide will continue to serve as PI of the AADCRC and administer the grant through Core A inconsultation with the program executive committee comprising PIs of the three individual projects (Broide,Croft, Zuraw) as well as key co-investigators (Hamid, Proud, Leigh, Ramsdell). Dr Broide will ensure that theadministrative, scientific, and fiscal responsibilities of the AADCRC are carried out as proposed.

Public health relevance
Inhalation of airborne allergens such as cat and dust mite or respiratory viruses may result in damage and scarring of the bronchial tubes in susceptible asthmatics. This Administrative Core A will ensure that the administrative, scientific, and fiscal responsibilities of the AADCRC are carried out.